Florida Summer Institute for Biostatistics and Data Science

ABSTRACT
Florida Atlantic University (FAU), the University of Miami (UM) and Florida International University (FIU)
propose a six-week Florida Summer Institute in Biostatistics and Data Science (Florida SIBDS) focused on
health disparities related to cardiovascular and infectious diseases. At present, Florida SIBDS would be the
first SIBDS in the southeastern United States. FAU and FIU are both Hispanic Serving Institutions (HSI) and
State Universities, and the University of Miami is a pre-eminent private institution with significant diversity.
Florida SIBDS is innovative: 1) It introduces rigorous quantitative careers to primarily Hispanic and African-
American young adults through the combined efforts of three ethnically diverse institutions; 2) The diverse
leadership team and faculty have unique complementary skillsets in biostatistics, epidemiology, health
economics, computational biology, AI, machine learning (ML), and big data analytics; and 3) SIBDS students
will be actively involved in “learning through teaching” to others, culminating in a short curriculum they will
teach to first year high school students. This novel partnership approach will address the shortage of
biostatisticians in government, academia and industry by providing a diverse, well-qualified pipeline of future
biostatisticians, many of whom may not have had the opportunity due to lack of awareness, educational access
and financial barriers. Florida SIBDS will recruit nationally to enroll 136 undergraduate and early graduate
school students over five years with requisite mathematics coursework and a budding interest in health, while
targeting groups typically underrepresented in the biomedical and behavioral sciences; recruitment methods
include social media, websites, professional organizations and personal contacts with administration and
student influencers. Florida SIBDS will engage students in a multi-faceted, peer and faculty mentored,
intensive 6-week training experience driven by research questions that highlight health disparities and social
drivers of health, using current cardiovascular, COVID-19 and HIV databases. Although the curriculum
encompasses basic, advanced and cutting-edge statistical and data science methods delivered in ways to
engage students, it also highlights scientific communication, collaborative skills, project teamwork, social
interactions and career guidance. Quantitative and qualitative methods will be used to evaluate peer and
faculty mentors and students annually. An External Advisory Committee, pedagogy and evaluation consultants,
leadership team and student advisors will use their experience and these data to inform the curriculum. Florida
SIBDS alumni will retain mentorships with faculty and have access to revised curriculums for five years after
completion.

Public health relevance
PROJECT NARRATIVE The Florida Summer Institute in Biostatistics and Data Science (Florida SIBDS) addresses the critical shortage of biostatisticians and inclusion of a pipeline of qualified young adults from groups typically underrepresented in the behavioral and biomedical sciences. Florida SIBDS is lead by experienced senior biostatistics faculty with strong commitments to teaching, collaboration and conduct of clinical and translational research. Students will participate in learning exercises and receive mentorship by faculty and peers regarding curriculum and career goals.